Investigating the mechanistic consequences of fentanyl-induced hypoxia and cardiorespiratory collapse

PROJECT SUMMARY
Acute exposure to ultrapotent synthetic opioids (UPSO), such as fentanyl, represents a significant public health
concern. In the ongoing opioid epidemic, it is estimated that UPSO exposure contributes to over 80% of
overdose-related deaths. The current defense strategy against UPSO exposure has been the development of
reversal agents, such as naloxone, that aim to effectively reverse opioid-induced respiratory depression and
related secondary complications with breathing. However, the high potency of UPSO decreases the window of
time in which a counteragent can be administered before UPSO-dependent cardiorespiratory collapse (CRC)
occurs and immediate resuscitative action is required. Optimal strategies for resuscitation following UPSO-
dependent CRC are unknown. Resuscitation increases the risk for hypoxic-ischemic reperfusion injury (HIRI),
which can lead to additional morbidity and death despite reversal of the opioid-mediated effects on breathing.
Critical knowledge gaps exist in understanding how UPSO exposure impacts post-resuscitative outcomes in vital
organ systems such as the heart, lungs, and brain. These gaps are a significant roadblock to successfully
minimizing the morbidities and mortalities associated with UPSO exposure. Proposal Objective: Establish a
foundational understanding of the cellular and systemic outcomes after reversing fentanyl-induced CRC (fiCRC).
We have developed a novel model of fiCRC where we observe pulmonary edema following naloxone
administration and reversal of respiratory depression, closely modeling documented clinical observations.
Central Hypothesis: Factors beyond respiratory depression contribute to the progression of fentanyl overdose,
leading to injury following the reversal of fiCRC; these factors are tractable targets in minimizing injury due to
fentanyl overdose and its reversal. We propose the following aims to test this. Aim 1: Characterize how fentanyl
and the reversal of OIRD impact the relationship between breathing and O2 consumption, mitochondrial activity,
and tissue-specific glucose metabolism. Aim 2: Characterize physiological outcomes of fentanyl overdose and
reversal of fiCRC in the cardiopulmonary system and brain. Aim 3: Test the efficacy of adjunctive strategies
during naloxone-mediated reversal of fiCRC to improve outcomes in the cardiopulmonary system and brain. This
proposal and its aims align with RFA-DA-23-056 to support mechanistic investigations into persistent/delayed
pathophysiological effects following acute UPSO exposure.

Public health relevance
NARRATIVE Ultrapotent synthetic opioids, like fentanyl, are highly toxic agents that pose a significant public health risk and can cause near-immediate cardiorespiratory collapse requiring resuscitative action. This proposal aims to provide resolution into the cardiopulmonary and neurophysiological outcomes following resuscitation from fentanyl-induced cardiorespiratory collapse. We will examine mechanisms contributing to reperfusion injury and test how targeting such mechanisms during reversal of fentanyl-induced cardiorespiratory collapse affects survival and physiological outcomes.